Molecular basis of centriole duplication

A micrometer-scale PCM is densely packed with a few hundred copies of several hundred different proteins. How the PCM space is organized to operate with optimal assembly functionality remains poorly understood. In this regard, our finding that the inner PCM space is structured by a higher-order Cep63-Cep152 self-assembly with a level of liquid drop-like self-interactive properties represents a paradigm shift in the understanding of the architecture and function of the centrosome. The cylindrical self-assembly we reported is the first near micrometer-scale intracellular architecture generated through a stepwise self-assembly process in a three-dimensional space. Given the architectural conservation of centrioles from worms to humans, our work could serve as a prototype for understanding the organization and function of various PCM assemblies in other organisms. In addition, since mutations in Cep63 and Cep152 are linked to the development of microcephaly, this study could generate a far-reaching impact on human health.